Silent Allosteric Modulation of mGluR5 for Safe and Effective Therapy of Alzheimer's Disease

SUMMARY
This project seeks to develop a novel disease-modifying compound for Alzheimer’s disease (AD). Synapse loss
in AD brain has been tightly correlated with cognitive symptoms and is triggered initially by amyloid beta (Aß)
peptide accumulation. We have described a pathway in which soluble Aß oligomers bind to Prion Protein, thereby
engaging mGluR5 as a co-receptor, and activating PTK2B (Pyk2) and Fyn kinases to couple with Tau pathology
and synapse loss. mGluR5 is a GPCR, and multiple groups have shown that interrupting mGluR5 function
rescues preclinical AD phenotypes, making it an attractive drug target. However, mGluR5 has a physiological
role as a glutamate receptor and full inhibition impairs function. Consequently, typical antagonists have a narrow
therapeutic window.
Yale has obtained an exclusive license to an extensive mGluR5-directed compound library with robust
Intellectual Property protection. Within this chemical collection, we identified a highly potent, orally bioavailable
mGluR5 ligand that does not alter basal or glutamate activity, but does block Aßo/PrPC activation of mGluR5.
This compound is considered a silent allosteric modulator, or SAM, for mGluR5, meaning “silent” with regard to
glutamate, while antagonistic with regard to Aßo/PrPC. Preliminary studies demonstrate robust efficacy of this
SAM compound for multiple preclinical mouse AD phenotypes. Drug treatment recovers synapse density,
restores LTP and returns memory performance to WT levels. While closely related mGluR5 ligands have
extensive selectivity and DMPK data, these are not yet developed for the SAM compound at this Early Stage,
and we propose to obtain them here for this lead candidate. The overall goal is to develop disease-modifying
oral therapy effective to slow, halt or partially reverse AD progression both in the MCI state and in mild dementia.

Public health relevance
NARRATIVE Today, no disease-modifying therapies for AD are available. Synapse loss in AD brain has been tightly correlated with symptoms and is triggered initially by amyloid beta peptide accumulation. We have mapped a pathway from amyloid beta oligomers to synapse loss. In this pathway, mGluR5 blockade is shown to improve function and synapse number in animal models. However, mGluR5 has a physiological role as a glutamate receptor and it is important to avoid blocking normal brain physiology while alleviating AD damage mechanisms. We identified a drug candidate that targets mGluR5 with high potency and specificity, leaving glutamate receptor function unimpaired while blocking only its connection with AD pathology. Here, we aim to develop this compound to slow, halt or partially reverse AD progression both in the MCI state and in mild dementia.